Online System for Primary Care to Prevent and Address Teen Substance Use

Substance? ?Use? ?Project? ?Summary Substance? ?use? ?usually? ?(90%)? ?begins? ?during? ?adolescence,? ?causing? ?brain? ?and? ?liver? ?damage,? ?risky sexual? ?and? ?driving? ?behavior,? ?and? ?potentially? ?leading? ?to? ?addiction? ?therefore? ?prevention? ?and? ?early intervention? ?programs? ?targeting? ?teens? ?are? ?needed? ?to? ?prevent? ?this? ?morbidity,? ?gain? ?productive years? ?of? ?life? ?and? ?reduce? ?costs.? ?? ?This? ?proposal? ?presents? ?innovations? ?to? ?overcome? ?the? ?barriers? ?to effectively? ?addressing? ?teen? ?substance? ?use? ?during? ?primary? ?care? ?visits? ?through? ?further development? ?of? ?a? ?promising? ??c?omputerized? ?alcohol? ?and? ?substance? ?use? ?computerized? ??S?creening and? ?provider? ??B?rief? ??A?dvice? ?system? ?(cSBA)? ?and? ?integration? ?with? ?an? ?online? ??clinical? ?process support? ?system?? ?called? ?CHADIS.? ?? ?CHADIS? ?addresses? ?all? ?pediatric? ?screening? ?needs? ?and? ?is currently? ?widely? ?used? ?in? ?pediatric? ?practice? ?making? ?widespread? ?dissemination? ?of? ?a? ?CHADIS-cSBA module? ?immediately? ?feasible.? ?? ?? ?However,? ?because? ?of? ?limitations? ?related? ?to? ?time? ?and? ?training? ?the approach? ?of? ?motivational? ?interviewing? ?(MI),? ?with? ?strong? ?evidence? ?for? ?effecting? ?behavior? ?change in? ?substance? ?users,? ?was? ?not? ?a? ?part? ?of? ?cSBA.? ?? ?An? ?innovation? ?proposed? ?here? ?will? ?take? ?pre-visit? ?teen data? ?related? ?to? ?strengths? ?and? ?goals? ?and? ?acknowledged? ?reasons? ?for? ?usage? ?to? ?populate individualized? ??teleprompters?? ?accessible? ?at? ?the? ?moment? ?of? ?care? ?by? ?PCP?s? ?along? ?with? ?options? ?for sharing? ?graphical? ?representations? ?for? ?use? ?in? ?reinforcing? ?abstinence? ?or? ?motivate? ?discontinuing usage.? ?? ?In? ?addition,? ?the? ?prompts? ?for? ?discussion? ?of? ?teen? ?identified? ?strengths? ?and? ?goals? ?will? ?include wording? ?from? ?teen? ?studies? ?using? ??incremental? ?theory?(or? ?? ?the? ?belief? ?that? ?people? ?have? ?the potential? ?to? ?change),? ?which? ?has? ?shown? ?result? ?in? ?improvements? ?in? ?social? ?coping.? ?? ?CHADIS-cSBA will? ?also? ?provide? ?each? ?teen? ?a? ?confidential? ?individualized? ?portal? ?automatically? ?populated? ?with supports? ?for? ?their? ?endorsed? ?strengths? ?and? ?other? ?supports? ?as? ?well? ?as? ?substance-related? ?follow-up messaging.? ?? ?Post-visit? ?parent? ?education? ?will? ?include? ?access? ?to? ?a? ?Teen? ?Safe? ?course.? ?? ?Teens? ?found? ?to have? ?serious? ?substance? ?abuse? ?or? ?dual? ?diagnoses? ?will? ?have? ?referrals? ?facilitated? ?by? ?care coordination? ?functionality.? ?? ?PCP? ?participation? ?will? ?be? ?reinforced? ?by? ?a? ?American? ?Board? ?of Pediatrics? ?accredited? ?quality? ?improvement? ?program? ?for? ?their? ?required? ?re-certification? ?(MOC-4). In? ?Phase? ?1,? ?the? ?CHADIS-cSBA? ?module? ?will? ?be? ?created? ?with? ?both? ?professional? ?and? ?teen? ?feedback and? ?MOC-4? ?certification? ?obtained.? ?? ?In? ?Phase? ?2? ?the? ?resulting? ?system? ?will? ?be? ?piloted;? ?a? ?baseline? ?of substance? ?use? ?screening? ?conducted;? ?then? ?CHADIS-cSBA? ?module? ?will? ?be? ?randomly? ?assigned? ?to doctors? ?and? ?a? ?quality? ?improvement? ?intervention? ?will? ?be? ?conducted? ?to? ?measure? ?reduction? ?in? ?rates of? ?any? ?substance? ?use? ?at? ?3? ?and? ?12? ?month? ?follow-up? ?compared? ?to? ?treatment? ?as? ?usual.

Public health relevance
Substance Use Project Narrative This proposal will create innovations to overcome the barriers to effectively addressing teen substance use (SU) in primary care visits through further development of a promising c omputerized alcohol and substance use computerized S creening and provider B rief A dvice system (cSBA) and integration with an online “clinical process support system” (CHADIS). The planned enhancements in the new CHADIS-cSBA module will address barriers of time and doctor training through: collection of comprehensive pre-visit data in an online questionnaire that has interactive education about SU; individualized “teleprompters” for the doctor to use for supporting teen strengths and conducting a motivational interview (MI) to quit or reduce use pre-populated by questionnaire results; post-visit education and resources automatically provided in a confidential individual portal; parent video education about SU; and a parent-teen Contract for Life. The CHADIS-cSBA system will be developed with teen and professional interview input and then tested for effectiveness through a randomized control quality improvement trial supplemented by Board recertification credits for doctors with the outcome to be measured of reduced rates of substance use at 3 and 12 month follow-up compared to treatment as usual.